Fronto-sensory circuit mechanisms of perceptual novelty processing

PROJECT SUMMARY Sensory stimuli are naturally perceived within a spatiotemporal and behavioral context, wherein novel events are processed and repetitive elements ignored. Novelty detection is thus cognitive as well as perceptual and is critical for daily function and survival. Studies using “oddball” stimuli demonstrate that psychiatric disorders, including schizophrenia (SZ), involve abnormal sensorineuronal processing of novelty which predicts deficits in cognition and everyday functioning. In his PhD, the candidate characterized the multivariate complexity and heritability of oddball EEG responses to show how they could help build a biological taxonomy of psychosis. Yet a mechanistic understanding of how brain circuits process context, and the pathophysiology underlying patient deficits, is unattainable with human studies alone. As a postdoc, the candidate mastered two-photon calcium imaging (2P-Ca++) and chemicogenetics to develop a mouse model of novelty detection in visual cortical circuits (V1), showing a key role for somatostatin interneurons, a pathophysiologically relevant cell type in SZ. While context processing involves ongoing adaptations within sensory cortex, it also requires information about the past and behavioral goals, which may implicate larger brain networks involving prefrontal cortex (PFC). AIM1 expands the candidates work in V1 to study the mechanisms and nature of PFC’s top-down influence. Experiments will test how direct axonal inputs from PFC actively modify the multicellular circuit dynamics in V1 during in oddball paradigms. To this end, the candidate must learn a state of the art holographic technique using spatial light modulators (SLM) developed in the host lab (NIkolenko et al, 2008; Yang et al 2016) to enable the i) simultaneous observation of layer I (PFC axons) and underlying layer 2-5 (V1 neurons) with fast 3D 2P-Ca++, and ii) holographic optogenetic manipulation of specific circuit elements (e.g. PFC inputs to interneurons) to uncover the causal interactions among three critical neurobiological scales: cells, ensembles, and networks. Patient oddball studies highlight deficits in both passive (automatic) and active (attentional) aspects of novelty processing, which may involve non-overlapping neural pathophysiology. In AIM2, the candidate will uncover the behavioral relevance of this PFC-V1 circuit. Working closely with consultants Drs. Churchland and Gogos, the candidate will learn to design behavioral training protocols in head-fixed mice, eliciting responses to novelty in a dynamic oddball paradigm. Building on findings from in AIM1, the candidate will differentiate attentive from pre-attentive circuit functions and establish when and how context is encoded and used to guide behavior. These studies will yield i) biomechanistic information for interpreting novelty processing deficits in humans and ii) key insights into how emergent activity of the cerebral cortex arises from cellular diversity and interregional connectivity. This work will position the candidate to pursue his career goal of a research program which translates empirical biomarkers of sensory and cognitive deficits to model systems, wherein basic research with cutting edge neuroscience tools can provide promising insights and strategies for novel treatments.

Public health relevance
PROJECT NARRATIVE Individuals with schizophrenia and other psychotic disorders exhibit abnormalities in basic sensory processing which undermine how they relate and adapt to a changing environment. While aberrant processing of novel stimuli in particular predates disease onset and predicts global functioning deficits in patients, these abnormalities are not mechanistically understood. The proposed project harnesses cutting edge optical tools to provide a comprehensive understanding of how prefrontal brain regions modulate sensory cortices at circuit levels, providing novel insights for future developments of treatments for a specific cognitive perceptual domain.